Building Research Capacity to Address Sociobehavioral Sciences in HIV infection in Tanzania

Abstract
This D43 application “Building Research Capacity in Sociobehavioral Sciences in HIV Infection
in Tanzania” is a competitive renewal of two previous D43 awards to Duke University, now
transitioned to the Kilimanjaro Clinical Research Institute (KCRI) with Dr. Blandina Mmbaga
serving as Program Director. The objectives of this Program include assembly of an
interdisciplinary team of sociobehavioral and related scientists who study HIV infection. Past
and future trainees are gaining expertise in cross-cutting approaches to prevention strategies,
HIV testing, retention in care, adherence to antiretroviral therapy, related co-morbidities
especially mental illness, the needs of vulnerable populations such as children and adolescents
with HIV, and an aging population of persons with HIV in Tanzania. These topics are aligned
with priority areas identified by the US National Institutes of Health, the Tanzanian Ministry of
Health, Community Development, Gender, Elderly and Children, and the 2021 PEPFAR
Country Operating Plan for Tanzania.
Social determinants and human behavior including mental illness represent primary obstacles to
successful HIV prevention and treatment, and our team has and will continue to expand the
evidence base to address these obstacles. In the previous two funding cycles, this Program
has trained 23 researchers who returned to KCRI including 18 in degree-awarding programs,
and trainees have published 128 manuscripts and received numerous fellowships and research
awards.
Given the evolving Tanzanian HIV epidemic and institutional needs, in the next cycle, the
Program will add seven new members and further diversify the KCRI research team through
subspecialty training in Child and Adolescent and Geriatric Psychiatry for two physicians trained
in General Psychiatry, two PhD level Psychologists, and strengthen the team's ability to address
social determinants and community outreach capacity with two psychiatric social workers and
one occupational therapist. At the completion of the next cycle, this interdisciplinary team will
be a formidable enterprise with the expertise to research sociobehavioral sciences and HIV
infection at the vanguard of contemporary knowledge. In addition to these trainings, an annual
Sociobehavioral Sciences in HIV Infection Symposia will enhance interest across KCRI, the
Kilimanjaro Christian Medical Center (KCMC), the Kilimanjaro Christian Medical University
College (KCMU Co) and the community. In order to support former D43 trainees who have
completed their didactic training, this cycle will offer funds to support competitive mentored pilot
projects. Prevailing methods to strengthen team science including peer-to-peer and faculty
mentoring will be enhanced, and competitive mentored pilot grants, leading to an
interdisciplinary collaboration with robust and sustainable capacity compete for external funding
to address Tanzanian priorities in sociobehavioral sciences in HIV infection.

Public health relevance
Narrative Currently there are highly effective treatments and prevention for HIV infection, but they are not being optimally utilized in low- and middle-income settings. Sociobehavioral determinants and mental illness represent significant obstacles to their full implementation. This D43 application, "Building Research Capacity for Sociobehavioral Sciences and HIV Infection in Tanzania", will continue to build research expertise to address and overcome these obstacles in Tanzanian context.